ORAL DISSOLVING STRIPS FOR THE DELIVERY OF ISONIAZID IN CHILDREN AND ADULTS

This projects aims to develop an oral dissolving strip product that delivers 300 mg of isoniazid for the treatment of tuberculosis; the optimized product will be tested in an animal model.